Neural circuit mechanisms of drug-context associations in the hippocampus

PROJECT ABSTRACT
Addictive drugs usurp the normal neural machinery for learning and memory to generate pathological cognition
that can lead to compulsive drug usage. One prominent example is re-exposure to a drug-associated
environmental context, which robustly induces drug relapse in both humans and animal models. The
hippocampal formation, which is critical for spatial and contextual learning, is well positioned to support the
encoding of this type of drug-context association. Despite decades of hippocampal studies on drug-evoked
molecular and cellular adaptations and drug-seeking behaviors, we still lack a clear understanding of which
hippocampal circuits are involved in acquiring and maintaining maladapted drug-context associations and how
neural dynamics in the hippocampus are transformed to support drug-seeking behavior. Moreover, there are no
interventions that specifically target the drug-associated memories to treat substance use disorders. Here, with
the proposed training in computational modeling for neural dynamics and the development of advanced genetic
and imaging tools, I aim to fill these knowledge gaps by elucidating the neural circuit mechanisms in the
hippocampus for drug-context associations and probing whether we can reverse this association using a
memory-based intervention. Preliminary data suggest opioid reward vs. withdrawal-mediated associative
learning have distinct effects on representing different spatial variables in CA1 neurons and ketamine was able
to reset the maladapted contextual representation to disrupt the retrieval of drug-associated memories. For Aim
1, I will investigate how drug-associated information alters the neural coding in the hippocampus for multiple
spatial variables that are critical for the perception of a given context. Using miniscope imaging in morphine
conditioned place preference/aversion, I will learn to build linear-nonlinear Poisson (LNP) models to reveal how
drug-context associations under positive vs. negative reinforcement affect the neural coding of CA1 for position,
head orientation, running speed and their conjunctions. For Aim 2, I will test the hypothesis that Ketamine
disrupts learned drug-context associations by restoring the maladapted representations of functional cell types
(e.g., place cells) to their normal state. I will acquire expertise on opioid withdrawal and investigate ketamine’s
effect on withdrawal-context associations by targeting memory reconsolidation and reveal the corresponding
change in neural dynamics of CA1. For Aim 3, I will elucidate neural circuit assembly and dynamics for coding
drug-associated contextual information in the subiculum, a major downstream target of the hippocampal CA1.
This study will leverage my training in Aim 1 and 2 to advance our understanding of the principles for processing
drug-associated information in the brain. Together, the proposed training and studies will not only help me to
establish an independent research program but also provide a mechanistic understanding of how hippocampal
neurons encode and represent drug-associated contextual information and shed light on developing novel
therapeutic treatments for substance use disorders.

Public health relevance
PROJECT NARRATIVE Addictive drugs usurp the normal neural machinery for learning and memory to generate maladapted pathological cognitions for compulsive drug seeking. The neural circuits governing drug associative learning interface between the drug-evoked molecular cellular adaptations and drug-seeking behaviors. A mechanistic understanding of these neural circuits is of major significance for advancing our knowledge on drug-induced cognitive states and developing novel therapeutic treatments for substance use disorders.